Evaluating the role of the novel apoptosis inhibitor TRAILshort, in maintaining HIV persistence

PROJECT SUMMARY HIV infected cells escape normal host immune responses. One pathway that the immune system uses to kill virally infected cells is TRAIL, which is expressed on activated T cells or NK cells. We have studied TRAIL involvement in HIV infection for ~15 years and discovered that (i) despite expressing TRAIL receptors, HIV infected cells are paradoxically resistant to the pro-death effects of TRAIL, and (ii) we discovered a splice variant of TRAIL that is produced by HIV+ cells which we have called TRAILshort. TRAILshort binds to TRAIL receptors and prevents normal (full length) TRAIL from killing these cells. We therefore created fully-humanized anti-TRAILshort-specific antibodies that sequester TRAILshort, and tested it in acute in vitro HIV infection. Anti TRAILshort antibody (or genetic inhibition of TRAILshort production) causes more HIV infected cells to die during acute infection, resulting in reduced HIV viral replication. We next analyzed publicly available RNAseq datasets from 253,200 human samples and identified TRAILshort exclusively in samples from donors with active infectious diseases, and/or human malignancy. We have since published that ~40% of human cancers express TRAILshort (by immunohistochemistry and in situ hybridization), and that primary B cell malignancies are inefficiently killed by autologous T cells, yet in the presence of TRAILshort antibody, that killing is significantly enhanced. We also observed that T cells exposed to cognate antigen proliferated more in the presence of anti-TRAILshort antibody, than in the absence, suggesting that TRAILshort might also directly impact T cell function and proliferation. Proteomic data presented herein show that TRAILshort treatment of primary T cells results in intracellular T signaling, changes in the cellular phosphorome, alterations in regulators of T cell activation and function (e.g. p38, ERK, JNK and Akt). In primary T cells treated with TRAILshort protein, we observe p38 phosphorylation at residues 180/182 by western blot, and impaired T cell activation induced by T-cell receptor (TCR) ligation (reduced CD25 and 69, less CFSE dilution and reduced Zap70 Lat phosphorylation by western blot), altogether indicating that TRAILshort is immunosuppressive to T cells. We will advance our understanding of the effect of TRAILshort on HIV specific T cell function by (i) testing the effect of TRAILshort antagonism on restoring HIV-specific T cell killing of productively HIV infected cells and latently HIV infected CD4 T cells induced to reactivate from latency, (ii) using advanced phospho-proteomic and biochemical techniques to understand how TRAILshort binding to TRAIL receptor 2 alters T cell homeostasis and (iii) study TCR-induced cell activation in the presence or absence of TRAILshort, to define defects in TCR signaling, reversing the defect using genetic and small molecule approaches, as well as TRAILshort antibodies.

Public health relevance
PROJECT NARRATIVE People living with HIV (PLWH) are able to generate an immune response, including a T cell response, to the virus that unfortunately is inadequate to cure the infection. T cells use a variety of “bullets” to kill their target cells (e.g. HIV infected cells) with one of those bullets being a protein called TRAIL; we have discovered that HIV infected cells make a protein which opposes the effects of TRAIL, called TRAILshort. The focus of our proposed research is to increase our understanding of TRAILshort by investigating (i) how blocking the effects of TRAILshort allows T cells to kill HIV infected cells, including latently infected T cells induced to reactivate HIV, (ii) how TRAILshort impacts T cells alone, and (iii) how TRAILshort impairs, and TRAILshort blockade enhances, T cell proliferation, and consequently target cell killing.